PLANT COLLECTION &TAXONOMY (SOUTHEAST ASIA)

To continue the exploration of selected tropical regions of the world as a source of potential new agents, which can be developed for the selective treatment of cancer, and AIDS in humans. This plant collection shall be conducted in Southeast Asia, with emphasis on Papua New Guinea.